Regulation of DNA double-strand break repair pathway choice

Project Summary
The general goal of the proposed research is to define the mechanistic underpinning for the synthetic lethality
network between a deficiency in homologous recombination (HR) and defects in single-strand annealing
(RAD52) or POLq-mediated end-joining (TMEJ). Exciting preliminary data revealed that BRCA2 and RAD52
delay the repair of S-phase-associated DNA double-stranded breaks (DSB) by TMEJ until M-phase. While the
parent award focuses on BRCA2, this supplement application focuses on RAD52. Our results will have potential
translational implications for the clinical application of newly developed RAD52 and POLq inhibitors for the
treatment of HR-deficient tumors with respect to application protocols, patient selection, and use of DNA damage
response checkpoint inhibitors as well as the response to poly(ADP-ribose) polymerase inhibition.
The Specific Aims are:
1. Define the mechanism of action of BRCA2 in DSB repair pathway control. We will test the model that the
DNA binding properties of BRCA2 are critical for TMEJ inhibition. In Aim 1A, we conduct foundational studies
to determine the fundamental DNA binding properties of full-length BRCA2. In Aim 1B, we will define which
domains of BRCA2 are required for TMEJ inhibition in cells. This combination of cell-based and biochemical
studies will define the functions and regions of BRCA2 that are required for TMEJ inhibition.
2. Define the mechanism of TMEJ inhibition by BRCA2 and RAD52. BRCA2 and RAD52 employ two different
modes to inhibit the DNA polymerase activity of POLq which may affect additional reaction steps in the TMEJ
process. We will reconstitute TMEJ in vitro with purified proteins to determine the mechanisms by which
BRCA2 (Aim 2A) and RAD52 (Aim 2B) inhibit TMEJ. We will test inhibition of the overall TMEJ reaction and
individual steps including 1) DNA binding, 2) end-alignment, and 3) DNA synthesis. Analysis of wild type and
catalytic mutants of POLq will be conducted in vitro and in cells.
3. Define which HR defects are susceptible to RAD52 loss of function. It is an open question whether loss
of RAD52 will lead to POLq-mediated chromosome fusions and lethality in all HR-deficient backgrounds (Aim
3A) or all BRCA2 mutants (Aim 3B). Our preliminary studies suggest a model that loading of BRCA2 is the
critical step to limit TMEJ to M-phase and that HR defects past this step are not affected by RAD52 inhibition.
4. Impact of a RAD52 variant on DSB repair. This supplement application adds this additional Specific Aim
focused on RAD52 and the functional impact of a variant that is common in Latinos and appears to modify
risk in BRCA1/2 carriers.

Public health relevance
Project Narrative DNA double-strand break (DSB) repair is critical to maintain genomic stability mending DNA lesions that are induced by ionizing radiation and other common modalities of DNA damage-based anti-cancer therapies including topoisomerase I and II-targeted drugs as well as inhibitors of poly(ADP-ribose) polymerase (PARP). Homologous recombination involving BRCA2, single-strand annealing catalyzed by RAD52, and POLq-mediated end-joining are key cellular pathways for DSB repair. Our mechanistic findings are important for the understanding of the synthetic lethality network of BRCA2-defective cells, and the insights gained will help to stratify tumors that best respond to the inhibition of RAD52, POLq, and/or PARP.